Investigating Neural and Behavioral Alignment as a Mechanism of Social Interaction Challenges in Adolescents with Autism Spectrum Disorder

PROJECT SUMMARY/ABSTRACT
Autism spectrum disorder (ASD) affects 1 in 54 children in the United States and is characterized by difficulties
in initiating and maintaining social interactions, leading to negative impacts on real-world social functioning and
mental health. Therefore, an important target of intervention in ASD is improving social interaction outcomes,
particularly peer interactions in the sensitive time period of early adolescence. During early adolescence,
children with ASD lag behind their peers in social development, yet peer relationships are an increasingly
important determinant of mental health. One potential target of intervention for improving social interaction
outcomes in ASD is alignment, the degree to which two or more individuals are aligned in their neural signals,
behaviors, and emotions in time. Alignment includes neural similarity (the pre-existing similarity of individuals'
neural response to stimuli) and interactional synchrony (the dynamic adjustments in body position and facial
expressions that occur between interacting individuals). Alignment has been established as an important
predictor of social interaction success in typically developing individuals, and some preliminary work has
suggested that alignment may be atypical in interactions including individuals with ASD. However, alignment
and its associations with social interaction outcomes have not yet been examined in early adolescent peer
relationships in ASD. Furthermore, a promising mechanism of atypical interactional synchrony in ASD, atypical
social attention, has not been directly tested as a mediator between diagnosis and atypical synchrony. By
using ecologically valid methods to examine live social interaction behaviors and outcomes between dyads of
novel peers, this proposal will test alignment as a mechanism of peer interaction challenges in ASD in real-
world contexts. Two aspects of alignment, neural similarity (Aim 1) and interactional synchrony (Aim 2), will be
tested as predictors of social interaction challenges in dyads including an individual with ASD. Aim 3 will test
the hypothesis that atypical social attention mediates the relation between ASD diagnosis and atypical
interactional synchrony. Collectively, these experiments will not only examine diagnostic group differences in
alignment, but also quantify the impact of alignment on real-world social interaction success, and investigate a
potential mediator of relations between diagnosis and interactional synchrony. Peer interaction success in early
adolescence is a key determinant of mental health, and the identification of atypical alignment as a mechanism
of peer interaction challenges could lead to new targets of intervention to support social functioning in ASD.
This proposal is supported by an integrated training plan developed with an expert mentorship team. Three
training goals will ensure the applicant is well prepared to transition to a future independent research career
investigating the neural and cognitive mechanisms of social interactions: (1) acquiring technical skills in the
quantification of neural and cognitive processes of social interaction, (2) extending conceptual training in social
development and ASD, and (3) furthering research dissemination and mentorship skills.

Public health relevance
PROJECT NARRATIVE Atypical social functioning in individuals with autism spectrum disorder creates profound challenges for mental health, particularly in the sensitive period of early adolescence when peer relationship formation is especially critical. Using a naturalistic, interactive design, the proposed study will investigate neural and behavioral alignment as mechanisms of peer interaction challenges in adolescents with autism spectrum disorder. This investigation will provide critical information about targets of intervention for improving social interaction outcomes during the sensitive period of early adolescence in autism spectrum disorder.